Applying After-Action Reviews to Child and Family Teams to Improve Mental Health Service Linkage within Child Welfare Services

PROJECT SUMMARY (R34#1 After Action Reviews in CWS)
Half of child-welfare involved children and adolescents meet criteria for at least one current mental disorder1.
Shared decision-making for Action Plans is vital to the mental health and wellbeing of children and families in
Child Welfare Services (CWS), with fewer child removals and fewer recurrences2, thus resulting in decreased
risk of child trauma, behavioral concerns, and mental health concerns. Yet, neither parents nor caseworkers
perceive that Action Plans include mutual influence3, and parents feel they have no voice or input4. Child and
family team (CFT) meetings are required for each child or youth within sixty days of entering CWS, and are
family-centered and collaborative ways to develop individualized, effective service plans based on mutual
agreement5. Relying on teamwork approaches, CFT meetings intend to give children and families a voice in
creating and guiding their case plans6, suggest children do better when connected to their families and empower
families to work with CWS agencies7,8, and address organizational need for teams to perform “complex,
interdependent, dynamic, and ambiguous tasks.”9 Yet, in CWS CFT meetings, the quality of teamwork can be
impaired by the inherent challenges of serving multiple needs and viewpoints that vary across family members
and professionals, as well as the pressures and constraints of CWS. Innovations from team effectiveness
research hold promise in facilitating improvements in shared decision-making within CWS. The after-action
review (AAR) is a relatively simple, inexpensive, quick, and powerful tool to improve learning, performance, and
the effectiveness of teams and individuals. AARs are active self-learning processes wherein team members
reflect on specific performance episode to actively engage in self-discovery and improve learning in a non-
punitive/non-judgmental manner. AARs have become a common tool that organizations have leveraged in
military, medical, educational, and other applications, to improve individual and team performance by
approximately 20-25%. This proposal aims to apply the team development intervention of the after-action review
(AAR) to improve implementation of the Child and Family Team (CFT) meetings currently used in the CWS. This
proposal will tailor and assess the impact of the AAR on enhancing CFT outcomes by addressing the following:
Specific Aim 1. Conduct a qualitative needs assessment targeting the ongoing implementation of the CFT clinical
intervention in a large, publicly funded, County CWS system; Specific Aim 2. Adapt and tailor the AAR team
effectiveness intervention to address the CFT services intervention needs; Aim 3. Assess mechanisms of the
AAR team effectiveness intervention for CFT implementation and a novel application of natural language
processing methods. Aim 3.a. Pilot-test the AAR implementation strategy on improving CFT outcomes, and
explore team mechanisms; Aim 3b. Identify and leverage CFT communication language data sources that are
feasible, naturally occurring, and appropriate for the CWS context to submit to methods core for aggregation
across projects.